Collaborative Pediatric Critical Care Research Network - Data Coordinating Center

Project Summary
In 2005, the Eunice Kennedy Shriver National Institute of Child Health and Human Development (NICHD)
established the Collaborative Pediatric Critical Care Research Network (CPCCRN) to support multi-institutional
randomized controlled trials (RCTs) and observational studies in critically ill children. The University of Utah is
prepared to support the proposed expansion of CPCCRN from seven clinical sites to 24 sites, which will en-
able CPCCRN to carry out the Personalized Immunomodulation in Sepsis-induced Multiple Organ Dysfunction
Syndrome (MODS) study. The DCC will play an important independent role in assuring regulatory compliance,
human subjects protection, and integrity of the trial results.
The DCC has two Speciﬁc Aims: (1) Provide independent clinical and biostatistical leadership and expertise,
assistance in study and protocol design, study implementation and management, tracking and delivery methods
for study drugs and biological specimens, study training, data collection and management, site monitoring, study
reporting, interim and ﬁnal study analyses, publication of study results, and production of public use research
datasets. (2) Provide logistical support for CPCCRN (including ﬁnancial management of protocol funds), us-
ing advanced communication and informatics tools for development and tracking of critical documents, including
study protocols, FAQ documents, Manuals of Operation, training materials, IRB and other regulatory documents,
study publications, DSMB reports, and provision of accounting information to NICHD.
The DCC has played a crucial leadership role during the ﬁrst 15 years of the CPCCRN. Clinical expertise has
enabled efﬁcient design and prioritization of CPCCRN studies to maximize productivity; biostatistical expertise
has been provided at every stage of study development and implementation; state of the art informatics tech-
nology has enabled efﬁcient communication within CPCCRN since its inception. We believe that the primary
criterion by which a DCC should be judged is the productivity of the sites and investigators supported by the
DCC. Investigators have successfully competed for nine R01 awards to increase the productivity of CPCCRN,
implementing 36 studies resulting in 119 peer reviewed publications. The CPCCRN will continue its outstanding
performance with the unique strengths that are contributed from the University of Utah DCC.

Public health relevance
Project Narrative The Collaborative Pediatric Critical Care Research Network (CPCCRN) includes 24 pediatric intensive care units and an established Data Coordinating Center with independent medical and biostatistical expertise. The University of Utah will provide the Data Coordinating Center to enable CPCCRN to carry out a large-scale multi- center randomized controlled trial using personalized testing and targeted management of immune function in infants and children with sepsis-induced multiple organ dysfunction syndrome (MODS), one of the most frequent causes of mortality and morbidity in critical care.